Personality and Dementia: Mechanisms and Trajectories

Summary/Abstract
Cognitive, emotional, interpersonal, and physical functioning are profoundly impacted by Alzheimer's disease
(AD) and related dementias. AD poses enormous public health and societal challenges, and the number of
affected individuals is expected to rise if an effective intervention to stop or at least slow AD progression is not
found. Research on the biological and psychosocial mechanisms that lead to dementia is essential to identify
appropriate targets for interventions. The scientific premise of the proposed study is based on robust evidence
for an association between long-standing personality traits and dementia-related outcomes. The mechanisms
through which these traits lead to cognitive changes, however, are not well understood. Furthermore, with the
onset and progression of AD, personality turns from a risk factor to a clinical sign of the disease, but the timing
and trajectory of such changes are not well understood. By integrating multiple theoretical perspectives (five-
factor model, lifespan models of personality and health, pathoplastic approaches to psychopathology, and
cognitive reserve), the proposed research will test three innovative aims. The first aim is to advance a
mechanistic understanding of the association between personality and dementia. We will test neurobiological
(e.g., MRI brain region volumes and white matter integrity), physiological (e.g., cortisol and cardiovascular
burden), behavioral (e.g., physical inactivity and smoking), and psychosocial (e.g., depressive symptoms and
loneliness) factors in the pathway from personality to cognitive decline and dementia. The second aim is to test
whether personality uncouples AD neuropathology from clinical dementia: We expect that, in the presence of
neuropathological changes, a resilient personality profile (low neuroticism, high conscientiousness) will delay the
time to onset of mild cognitive impairment (MCI) and dementia. The third aim is to identify the timing and trajectory
of personality change during the prodromal phase of AD and related dementias. To address the study aims, we
will leverage data from the Baltimore Longitudinal Study of Aging (BLSA). This ongoing prospective study include
measures of the five major personality traits, along with in-depth assessments of relevant risk factors and AD
biomarkers, and they involve long-term follow-ups (up to 40 years of serial assessments of personality in the
BLSA). By leveraging rich prospective data, the proposed project will identify the biological and psychosocial
mechanisms that underlie personality-based vulnerability and resilience to dementia and identify inflection points
for personality change in the earliest symptomatic phase of the disease.

Public health relevance
Project Narrative Change in personality and behavior is one of the clinical criteria for the diagnosis of dementia. To further understand the evolution of Alzheimer’s disease and related dementias, the proposed work aims to better define the timing and trajectory of personality change with the onset of mild cognitive impairment and the transition to dementia. Further, the proposed research on the behavioral and biological processes that lead to dementia among individuals with a vulnerable personality profile will contribute to the development of tailored interventions to increase resilience against cognitive decline and risk of dementia.